Change of Institution

Project Summary
Cardiovascular diseases represent the number one cause of morbidity and mortality worldwide, affecting a
broad spectrum of ages from babies that are born with congenital heart defects (CHDs) to adults that suffer
acute myocardial infarctions and/or develop congestive heart failure over time. My research program is
motivated by the simple assumption that we can use the zebrafish model organism to understand on a
molecular and cellular level how the cardiovascular system is established during development and how it
regenerates during adulthood. Here, I plan to leverage the longer-term support and increased scientific
flexibility afforded by the NHLBI R35 Emerging Investigator Award to continue and expand my laboratory’s two
main research focuses in great vessel morphogenesis and heart regeneration to address significant challenges
in each field. Specifically, I will use the genetic and regenerative attributes of the zebrafish system: (1) to model
human CHDs that disrupt great vessel establishment and, (2) to uncover critical barriers to mammalian heart
regeneration. In regards to the former, we have made paradigm-shifting observations concerning the cellular
etiology of the cardiovascular phenotypes present in DiGeorge Syndrome patients that are caused by
hemizygous microdeletions on chromosome 22q11.2, a region that harbors the TBX1 gene. We plan to delve
deeper into these cellular mechanisms and break new ground by identifying biologically relevant targets of the
Tbx1 transcriptional complex using a proprietary knock-in zebrafish strain. As ~20% of individuals carrying the
22q11.2 deletion lack any discernable pathology, we anticipate that the genes we discover as Tbx1
transcriptional targets will represent novel candidates that profoundly influence the severity of DGS
cardiovascular defects. We also plan to create new CHD models in an effort to link previously identified genetic
variants that segregate with great vessel CHDs in newborns to the pathology and to uncover the cellular and
molecular basis of disease. The outcomes of the proposed studies will contribute significantly to our fund of
knowledge and likely influence genetic counseling, pre-natal diagnosis, and possibly pre-natal repair.
Additionally, we have uncovered novel determinants of myocardial proliferation in regenerating zebrafish
hearts that likely contribute to the regenerative failures observed in mammalian hearts, including humans.
Specifically, we plan to further explore the required role of Notch signaling in zebrafish heart regeneration,
understand how alterations in the epigenetic landscape and in chromatin accessibility influence cardiomyocyte
proliferation, and determine whether myocardial ploidy affects regenerative capacity. The outcomes of the
proposed studies will directly guide future approaches to coax mammalian hearts towards regeneration instead
of scarring and identify practical inroads for regenerative medicine.
!

Public health relevance
Heart disease represents the number one cause of morbidity and mortality worldwide, affecting a broad spectrum of ages from babies that are born with congenital heart defects (CHDs) to adults that suffer heart attacks and/or develop congestive heart failure over time. My research program is motivated by the simple assumption that we can use the zebrafish model organism to understand how the heart is formed during development and how it robustly regenerates instead of scarring following injury during adulthood. Our discoveries are likely to impact genetic counseling, pre-natal diagnosis, and pre-natal repair of CHDs as well as guide future approaches to coax the diseased human heart towards regeneration instead of scarring.